An In Chemico Test to Identify Dermal Corrosives

Abstract
a
Exposure to dermal corrosives can occur during production, transport, use, and disposal of chemicals and
products. Such goods are manufactured and transported all over the world to different destinations, and the
transport of hazardous materials increases the likelihood of injury to the skin through improper chemical
release. New laws are being implemented that ban or severely limit the use of live animals for routine product
testing. Available nonanimal tests do not accurately identify dermal corrosives and no test for corrosives is
either high throughput or can be used in the field. There is thus a need for a nonanimal high-throughput
laboratory and field test to identify dermal corrosives; the subject of this proposal. Our preliminary research
discovered that a measurable change in the molecular structure of a marker protein predicts if a material has
the potential to damage and degrade human skin. Based on this finding, an "in chemico" (cell free, shelf stable)
test chemistry was developed, a patent application has been submitted, and preliminary "kits" have been
assembled (both a field test "kit" and a high-throughput laboratory test "kit"). The procedure involves adding
the material to be tested to a tube filled with a proprietary molecular marker for skin corrosion, incubating the
material at room temperature, and then adding a colorimetric reagent to measure the extent of conformational
change of the molecular marker and quantification using either a laboratory plate reader (high-throughput
laboratory method) or a portable spectrophotometric pipette (field method). This measured change is then
compared with the controls, and a "corrosion score" is calculated. The corrosion score is then applied to a
prediction model, and the test material is classified as a skin corrosive or noncorrosive. Initial studies
comparing results from the in chemico test with historical databases of live animal skin corrosion studies
("Draize Test" data) indicate the test has very high predictivity. This project will confirm the accuracy and
configuration of the test as a portable kit, and a transferability study will be conducted by three laboratories.
The outcome of this project will be a new, rapid, easy-to-use method that does not use animals and will
accurately determine if an unknown chemical or material corrodes and damages the skin.

Public health relevance
Narrative A Product and chemical testing for the potential to corrode the skin is conducted to ensure correct safety labeling so that individuals can take adequate precautions to avoid injury. This project will develop a new kind of nonanimal, high-throughput, field test to identify dermal corrosives that will improve the capabilities of manufacturers, first responders, and regulators to warn the public about chemicals and products that could potentially damage the skin. Successful development and validation of the new method proposed here will enable early, accurate, on-site warning and thereby reduce the chance of toxic chemical injury as well as potentially open a door to a new way of nonanimal toxicology testing that may be used for other classes of toxins and target tissues in the future.